Project 1

PROJECT SUMMARY
The goal of our studies is to generate robust and long-lasting tumor-specific T cell responses for durable
tumor regression in patients with chemotherapy-resistant high-grade serous ovarian cancer (HGSOC).
Although immunotherapy using immune checkpoint inhibitors (ICI), adoptive T cell therapy (ACT), or oncolytic
viruses (OV) have generated remarkable results in several tumor types (e.g. melanoma, NSCLC), long-term
tumor control has been infrequent in patients with HGSOC. Studies by our group and others have identified
key stumbling blocks underpinning the limited anti-tumor efficacy of immunotherapy in EOC. These include: (i)
insufficient expansion of tumor antigen-specific T cells, (ii) recruitment of Tregs and myeloid-derived
suppressor cells (MDSC) via tumor CXCL12 production, (iii) severe dysfunction of tumor-infiltrating T
lymphocytes (TIL) often by PD1 upregulation, (iv) low intrinsic tumor immunogenicity partially dependent on
reduced tumor mutation burden and IFNβ production, (viii) insufficient recruitment of intratumoral dendritic cell
populations (DC) capable of cross-presenting tumor antigens; (ix) tumor “vascular checkpoint” characterized by
disorganized and tortuous tumor vasculature lacking adequate flow dynamics to support trafficking of anti-
tumor T cells. While combinatorial immunotherapy strategies have the potential to overcome these immune
resistance mechanisms in the tumor microenvironment (TME), they are often associated with unacceptably
high rates of toxicities in patients. Our proposal addresses these stumbling blocks using innovative, clinically-
translatable strategies to reprogram the TME and to identify mechanisms that drive or hinder T cell trafficking
into ovarian tumors.
We previously demonstrated blockade of the CXCL12/CXCR4 axis in the ovarian TME by intraperitoneal
delivery of an oncolytic vaccinia virus expressing a CXCR4 antagonist (OVV-CXCR4-A-Fc) reduced
intratumoral accumulation of immunosuppressive mediators, stimulated spontaneous anti-tumor immunity to
endogenous tumor antigens, and improved T cell trafficking into the TME. Based on our observations, we
propose to test the hypothesis that in HGSOC patients receiving liposomal doxorubicin (DOX) for platinum
resistant/refractory EOC, in vivo tumor destruction by OVV-CXCR4-A-Fc will (i) abrogate tumor immune
suppression, (ii) promote trafficking and accumulation of tumor-specific T cells, and (iii) when combined with
PDL1 blockade, will limit T exhaustion and provide clinical benefit in a phase I/II clinical trial. The approach is
to first determine whether i.p. OVV-CXCR4-A-Fc is safe and triggers a transformation of the ovarian TME from
tolerogenic to immunogenic in a first-in-human clinical trial focused on patients with platinum
resistant/refractory EOC. Second, we will determine whether the combination of OVV-CXCR4-A-Fc and PDL1
inhibition is safe and can generate clinical efficacy. Third, we will test whether the combinatorial regimen
generates functionally distinct CD8+ and CD4+ effector/memory cells for shared antigens and neoantigens.
Finally, we plan to uncover the molecular mechanisms by which OVV-CXCR4-A-Fc overcomes the ovarian
tumor “vascular checkpoint” to enhance T cell migration and trafficking.

Public health relevance
PROJECT NARRATIVE The overall objective of this project is to reprogram the ovarian tumor microenvironment (TME) with an “armed” oncolytic vaccinia virus for local delivery of a CXCR4 antagonist (OVV-CXCR4-A-Fc) to minimize the potential for high rates of systemic toxicities. We will determine whether intraperitoneal OVV-CXCR4-A-Fc is safe and triggers a transformation of the TME from tolerogenic to immunogenic in a first-in-human clinical trial focused on patients with platinum resistant/refractory EOC. We plan to integrate immunologic and proteogenomic profiles to provide an exhaustive characterization of the interface between the TME and the immune system in order to examine the molecular mechanisms that generate functionally distinct effector/memory T cells against shared antigens, neoantigens and how vascular checkpoints regulate tumor-specific T cell trafficking into the ovarian TME.